Medical Scientist Training at UMCMS

PROJECT SUMMARY/ABSTRACT
Our MD-PhD Program was founded in 1983 and first obtained NIH MSTP funding in 2013. We currently have a
steady enrollment of about 80 students at all stages at any given time. Our Institutional leadership is highly
supportive of the Program, as is amply demonstrated by its investment in the Program. Our Program leadership
changed in December 2021, interrupting T32 funding but enabling substantial positive changes. The Mission of
the Program is to train a diverse group of physician-scientists who will excel in their chosen research fields through
innovative and high-impact research. We prepare them to become leaders in academic medicine and other
health-related enterprises. Our graduates will combine their investigative skills with their clinical experience and
expertise to produce new knowledge that will improve the health of both individuals and populations. Our Objectives
are that, throughout their professional careers, our trainees will 1) think critically and innovatively; 2) inform their
research through clinical observation and, conversely, apply a hypothesis-driven approach to their care of patients; 3)
conduct rigorous, reproducible, and transparent science as a fundamental focus of their professional activities; 4)
collaborate effectively with other researchers in academia, government, and the private sector. Other programmatic
objectives include 5) increasing faculty and student diversity, both scientific and sociodemographic; and 6) enhancing
our mentoring and evaluation structures. Historically, MD-PhD programs have focused on the basic sciences, and
UMass Chan has world-renowned basic scientists. However, our faculty also includes thought leaders in translational
science, and in population health sciences, including epidemiology, biostatistics, health informatics, data science,
and health equity research. We believe that physician-scientists trained in the population health will make significant
contributions to improving the health of both individuals and populations, and that the scarcity of MD-PhD
graduates with a focus on the population sciences is a missed opportunity for our country. We intend to maintain
the size of our MD-PhD trainee group, but we aim to increase the proportion of trainees in the population sciences
from about 10% to about 25%. Also, we have begun and will continue to restructure our Program with 1) markedly
enhanced and longitudinal mentoring with Individual Development Plans (IDPs) playing a key role and centrally
supported effort for mentors; 2) an intense focus on reducing time to dual degree (TTD) by eliminating redundancies
in the medical and graduate school curricula, a structured and mentored approach to choosing thesis advisors, and
requiring mentor training and attention to reducing TTD by thesis advisors ; 3) enhanced and early emphasis on
research-intensive residency selection; and 4) an entirely revamped evaluation system, with dynamic data-driven
feedback loops for Program improvement. We request 20 MSTP T32 slots each year, while institutional resources
will directly defray over 80% of the cost of our MD-PhD Program. Our Vision is that all of our trainees will pursue
careers as physician-scientists and contribute toward improving the health of individuals and populations through
medicine-inspired scientific discovery.

Public health relevance
PROJECT NARRATIVE We propose to train physician-scientists who will devote their careers to doing research inspired by their clinical activities. This will result in discoveries that will contribute to improving health for both individuals and the population at large. An important part of accomplishing this is to increase the diversity of our students and faculty.